The AD Knowledge Portal Data Coordination Center

ABSTRACT
Alzheimer's disease (AD) is a complex neurodegenerative disorder affecting millions of Americans, yet
therapeutic options to prevent, slow, or cure AD and related dementias (ADRD) remain limited. The
multifactorial nature of AD/ADRD along with a heterogeneous presentation across individuals, necessitates
multiple therapeutic approaches. The National Institute on Aging (NIA) has established a series of research
programs to diversify the therapeutic pipeline, including the Accelerating Medicines Partnership in Alzheimer's
Disease Target Discovery and Preclinical Validation project (AMP-AD) and dozens of additional consortia and
projects. These programs employ open science practices to understand the molecular complexity of AD/ADRD
and identify new avenues for treatment. The Data Coordination Center (DCC), led by Sage Bionetworks,
supports these programs by overseeing dissemination of research outputs through the AD Knowledge Portal
and the Agora Platform. These platforms have been widely utilized, with thousands of researchers having
accessed data and hundreds of publications referencing their use. The DCC also promotes cross-project
integrative analyses through working groups, which have yielded significant contributions in terms of
harmonized datasets and cross-consortium publications. As the AD Knowledge Portal Data Coordination
Center, we will leverage and expand our existing processes, systems, and infrastructure to further our mission
to accelerate translational research in AD. We propose to: 1) apply Findable, Accessible, Interoperable,
Reusable (FAIR) practices to define data and metadata standards and oversee data contribution and
governance; 2) use evidence-based strategies to engage the consortium in collaborative cross-team research
projects; (3) disseminate consortium-generated resources through the AD Knowledge Portal and Agora and
develop interoperability with the broader ecosystem of AD/ADRD data and resources; and 4) maximize the
impact of AD Knowledge Portal resources on basic and translational AD/ADRD research through outreach and
engagement with the broader research community.

Public health relevance
PROJECT NARRATIVE Alzheimer's disease is a complex brain disorder that affects millions of Americans, but there are limited options to prevent or treat it. The National Institute on Aging has funded numerous research groups that use open science to better understand the disease and develop new treatments. The AD Knowledge Portal Data Coordination Center helps these researchers collaborate with one another and share their findings through online platforms to improve our understanding of Alzheimer's and find effective treatments.